Tissue and Molecular Pathology (TMP)

The principal purpose of the Tissue and Molecular Pathology Shared Resource (TMP-SR) remains the
facilitation of tissue-based research by Rogel Cancer Center (Rogel) members. This SR was established in
1989 and approved by the NCI in 1991. TMP-SR has made major contributions to Rogel individual and multiinvestigator projects, thereby facilitating many discoveries and high impact publications. Key services include
Tissue Procurement Services (TPS), Histology/Immuno-histochemistry Services (HIS), a Frozen Tumor Bank
(FTB), an Anonymous Paraffin Bank (APB), Tissue Microarray Services (TMS), and Molecular Pathology
Services.